Microbial Adaptation and the Statistics of Epistasis and Pleiotropy

PROJECT SUMMARY/ABSTRACT
The overall goal of my research program is to understand adaptation in microbial populations, using a
combination of mathematical modeling and high-­throughput experimental evolution in budding yeast. At root,
we aim to predict how evolution chooses probabilistically among different mutational trajectories, to determine
the rate and outcomes of adaptation. In the short term, evolution depends primarily on the distribution of fitness
effects of individual mutations. However, on longer timescales epistatic interactions between mutations can be
crucial. Similarly, mutations often have different fitness effects in different environments (“pleiotropy for
fitness”). This is essential to evolution in fluctuating environments. Recent work shows that epistasis and
pleiotropy are strong and common among specific sets of mutations in many microbial systems. However,
these studies of specific limited sets of mutations cannot fully explain how epistasis and pleiotropy constrain
the rate, repeatability, or dynamics of adaptation. And even given a complete set of epistatic and pleiotropic
interactions, we are still often unable to predict how evolution will act. This severely limits our ability to
understand the evolution of complex phenotypes, such as compensated antibiotic resistance, multiple
mutations required for immune escape, or multiple gene knockouts enabling cancer evolution.
The central objective of this proposal is to examine the role of epistasis and pleiotropy for fitness in the
evolution of microbial populations. Rather than characterizing specific examples, we propose to survey the
overall statistics of epistasis and pleiotropy that are relevant for constraining microbial adaptation, and to
analyze how this epistasis and pleiotropy alters how evolution chooses among possible mutational trajectories.
In Aim 1, we will quantify statistical patterns of epistasis among both natural variants and mutations relevant to
adaptation in laboratory budding yeast populations. We will use our data to test recent theoretical predictions
describing how overall statistical patterns of epistasis emerge from individual idiosyncratic interactions. In Aim
2, we will measure patterns of pleiotropy across hundreds of environmental conditions, and use our data as the
basis for a novel computational method to infer lower-­dimensional statistical structure in the underlying
phenotypic space. Finally, in Aim 3, we will track evolutionary dynamics in fluctuating conditions in both clonally
evolving and outcrossed recombining laboratory budding yeast populations, using genetic systems we have
developed to control mating and to continuously barcode lineages. We will interpret these results within the
context of novel population genetic theory we will develop to predict how epistasis and pleiotropy affect
evolutionary dynamics in fluctuating environments. In contrast to recent work probing epistasis and pleiotropy
between restricted sets of individual mutations, our approach will provide a comprehensive picture of the
degree to which these factors alter the course of microbial evolution.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT/NARRATIVE Interactions between mutations (epistasis) and between mutations and changing environments (pleiotropy) are central to the evolution of many complex microbial phenotypes that directly affect human health, such as compensated antibiotic resistance and the adaptation of pathogens to immune selection. This project will provide a broad survey of the statistics of epistasis and pleiotropy, and will explain how these effects constrain the evolution of microbial populations. This will provide a basis for predicting the conditions under which complex microbial phenotypes relevant for public health are likely to evolve.